Core A - Administrative Core

Core A. Administrative
Abstract
The goals of the Administrative core will be: 1) coordinate effective interactions among projects,
cores, oversight committees, and NCI staff, 2) provide Data safety and Monitoring support, ensuring
that clinical trials are under the highest standards of “Good Clinical Practices” and that they comply
with all the regulations of the University and other outside agencies, 3) support interactions with the
Cancer Center and the Center for Cellular Immunotherapies, 4) support interactions with Industry,
and 5) provide budget support, such as tracking the expenditures of the program and providing
monthly reports to the investigators. This Core will also monitor Projects and other Cores and
organize a yearly meeting with the External and Internal Advisory Boards. Given these broad
integrative activities, the Core will interact closely with each Project and with the other two Cores in
providing administrative, financial, and coordinating activities.